Circular RNAs as novel mediators of cardiac repair

PROJECT SUMMARY
Cardiovascular disease is the leading cause of death and pharmacologic treatment strategies have
improved cardiovascular outcomes and survival. However, the prognoses of affected individuals remain
poor; hence, the need to elucidate underlying mechanisms and develop better therapies for
cardiovascular diseases. Our proposed studies focus on circRNA as an unexplored component of the
cardiovascular system to yield new understanding and tools for treatment of myocardial infarction. The
overarching objective of this current revised application is to reveal how circular RNAs (circRNAs), a
recently identified class of RNAs that are generated from many protein-coding genes, impact mouse
models of myocardial infarction (MI). Preliminary data generated for the current proposal shows that
modulation of a specific circRNA from the Fibronectin Type III Domain Containing 3B (FNDC3b) gene
(circFNDC3b) in ischemic myocardium can modulate cardiac repair after myocardial infarction in mice.
In particular, we found: 1) decreased circFNDC3b expression in post-MI mouse hearts and in left
ventricular tissues of ischemic cardiomyopathy patients, 2) and in endothelial cells and cardiomyocytes
in post-MI mouse hearts; 3) AAV9 mediated circFNDC3b overexpression enhances endothelial cell
angiogenesis and inhibits hypoxia-induced cardiomyoblast apoptosis in vitro, 4) and improves left
ventricular function, remodeling and neovascularization post-MI in mice; 5) circFNDC3b bind RNA
binding protein fused in sarcoma (FUS-1) in endothelial cells and cardiomyoblasts and regulate FUS-
1 levels. Our central hypothesis is that rescue of circFNDC3b promotes positive cardiac remodeling
after MI by enhancing neovascularization and improves cardiomyocyte cell survival through FUS-1
inhibition, thus improving cardiac function. This research will create a multi-modal platform for future
work, accelerating progress in this field as it relates to therapeutic targets and underlying mechanisms.
The hypotheses will be tested under the following 3 specific aims: Specific Aim 1: To determine the
physiological role of circFNDC3b on myocardial injury repair post-MI in mice. Specific Aim 2: To
elucidate the molecular mechanism by which circFNDC3b regulates cardiomyocyte cell survival and
enhances endothelial cell function. Specific Aim 3: To develop novel therapeutic strategies to
manipulate other circRNAs to promote myocardial injury repair post-MI in mice. Successful completion
of the proposed research will potentially identify circRNAs as potentially novel therapeutic targets for
ischemic myocardial repair.

Public health relevance
Narrative Certain diseases like myocardial infarction (MI) are the major cause of mortality in humans. IL-10 is a known cardio-protective cytokine that reduces inflammatory response, protects heart muscle cells and increases new blood vessel formation in the heart after injury. This project aims to understand the role of a newly discovered non-coding RNA known as circularRNAs in the regulation of ischemic heart repair in the context of inflammation and ischemia. Data obtained from proposed studies may potentially be crucial in understanding new mechanisms of ischemic heart repair and potentially identification of inflammation-regulated circularRNAs as new therapeutic targets.